Administrative Core A

Core A Project Summary/Abstract
Core A (Administrative Core) will oversee, facilitate and coordinate all GCAD activities carried
out by the other two cores. Core A will also coordinate analyses by investigators funded to
analyze Alzheimer’s Disease Sequencing Project (ADSP) data. Core A Specific Aims are: (1)
Coordinate acquisition of ADRD genetic, FG, and phenotype data; (2) Coordinate data
processing, harmonization and analyses; (3) Support/foster collaboration between ADSP
investigators and related projects; (4) Disseminate data and findings to a diverse group of ADRD
researchers; (5) Provide administrative support to GCAD including governance, Institution
Review Board (IRB) protocol review, and data sharing compliance.